Enhance the Capacity and Capabilities of Tennessee's Human and Animal Food Testing Laboratory in support of an Integrated Food Safety System (IFSS)

Overall
Abstract
The Food Safety Modernization Act (FSMA) outlines a new approach to food safety that is risk-
informed and preventive in focus. To develop prevention-based systems, sample data and other
information are needed to help identify and address hazards. This project will leverage state
laboratories (such as the Technical Services Laboratory of the Tennessee Department of
Agriculture) to produce a large quantity of high-quality sample data. These datasets will drive a risk-
based and prevention-focused food safety system that both the FDA and State partners
(Tennessee’s human and animal food regulatory programs) can utilize for tracking and trending,
early identification of emerging issues, and evaluation for future sampling initiatives and areas of
focus.
The Laboratory Flexible Funding Model (LFFM) is a cooperative agreement program, and therefore
the work accomplished within it is public health oriented and of mutual benefit to FDA and
Tennessee regulators. Specifically, within the Product Testing Tracks, FDA sets priorities for
commodity-hazard pairs and funded labs select what work aligns with their goals, capabilities, and
interests, in collaboration with State Regulatory Program (SRP) partners. Samples collected and
analyzed under the proposed work may be for a variety of purposes: regulatory, surveillance,
blinded studies, Total Diet Study (TDS), signals evaluation surveillance, baseline prevalence data,
etc.
Human and animal food finished products as well as in-process and raw ingredient samples will be
analyzed by the Tennessee Department of Agriculture to ensure they do not reach consumers with
harmful contaminants, to respond to emergency events, or to verify they contain ingredients at
levels as declared on product labeling. Environmental swabs from food production facilities may
also be analyzed as part of for-cause facility investigations in response to positive product
samples.
Overall, this proposal will strengthen and improve FDA’s efforts to prevent foodborne illnesses and
minimize foodborne exposures through building a nationally integrated laboratory science system
and equip partner laboratories, such as the Tennessee Department of Agriculture’s Technical
Services Laboratory, with additional resources that can be employed to build and increase sample
throughput capacity within the state.

Public health relevance
Overall Narrative Maintaining the safety and security of the US food supply is a joint priority for state and federal regulatory agencies, and the proposed work supports those efforts by furthering the laboratory component of the national integrated food safety system. Under this speciﬁc proposal, Tennessee Department of Agriculture officials will collect human and animal foods for chemical and microbiological testing, and their state laboratory partners will analyze the samples for contaminants, which may spark recalls to protect consumers or inform future education/enforcement efforts. This proposal will also support the development of new laboratory methods (to respond to emerging food concerns), testing capacity (to ensure that an adequate number of samples can be tested for surveillance or emergency response), and laboratory infrastructure (such as modern testing equipment).